EFFECT OF ORAL AND TRANSDERMAL ESTROGEN REPLACEMENT ON GH SECRETION IN WOMEN

Study whether equivalent levels of circulating estradiol obtained by oral and by transdermal administration promote the same degree of GH stimulation. Subjects will be studied on 3 occasions: pretreatment, after 14 days of treatment with oral estradiol, and after 14 days of transdermal estradiol treatment.